Optimization of fibroblast-selective inhibitors of YAP/TAZ as novel therapeutics for Pulmonary Fibrosis

PROJECT SUMMARY
Idiopathic pulmonary fibrosis is a chronic, progressive and conclusively fatal disease in which aberrant fibroblast
proliferation, contraction, and extracellular matrix (ECM) deposition causes lung function decline. Studies by our
group and others, have identified a pivotal role for Yes-associated protein 1 (YAP) and transcriptional coactivator
with PDZ-binding motif (TAZ) transcription co-factors in activating fibroblasts to drive fibrosis in the lung. Although
these studies highlight the YAP/TAZ transcriptional program as a potential target for drug discovery, the
multitude of signaling inputs modulating this pathway, YAP and TAZ ubiquitous expression, and their involvement
in a wide array of cell functions, including stem cell maintenance, epithelial and endothelial homeostasis, render
them challenging therapeutic targets. Therefore, a treatment strategy targeting YAP/TAZ in fibroblasts selectively
over epithelial and endothelial cells would provide a novel avenue to treat IPF. While we have shown that
fibroblast-selective inhibition of nuclear localization of YAP/TAZ reverses fibrosis in IPF mouse models using
dopamine receptor D1 agonists, challenges in development of such compounds into effective therapies have led
us to perform a target-agnostic high-throughput screen, which identified several selective small molecule hit
compounds with validated anti-fibrotic activity in cell-based assays. The goal of this phased R61/R33 proposal
is to further characterize and optimize our novel fibroblast selective YAP/TAZ inhibitors into potent and selective
compounds with validated anti-fibrotic activity in vitro and ex vivo, and with favorable in vitro ADME/PK properties
(R61 phase). We will then optimize drug-like in vivo properties for 1-2 lead scaffolds, confirming their anti-fibrotic
effects caused by cell type-selective inhibition of YAP/TAZ in in vivo IPF mouse models (R33 phase). Together,
the proposed experiments will generate lead molecule(s), which can serve as the basis for an effective therapy
to treat IPF patients.

Public health relevance
PROJECT NARRATIVE Idiopathic pulmonary fibrosis (IPF) remains a debilitating and ultimately fatal lung disease; current therapies marginally slow progression and have very limited improvements in overall survival. The YAP/TAZ transcription factors have been shown to play a central role in fibroblast activation and matrix deposition, but they also play essential roles in other lung-resident cell types. We have devised a cell-type selective approach that has allowed us to identify novel molecules that inhibit the fibrotic activity of YAP/TAZ in fibroblasts, and our proposed work will further optimize toward a lead compound that can be developed in to an effective therapy for IPF.